Novel molecular mechanism for extracellular release of proteins implicated in metastatic cancer

Project Summary/Abstract
Some critical proteins, with functions both inside and outside of cells, circumvent conventional secretion via the
ER and Golgi and are released through Unconventional Protein Secretion (UPS) pathways. These routes are
evolved either to spatially and temporally control the function and the triggered release of these UPS cargoes by
certain stimuli, or to activate upon impairment of the conventional pathway. Hence, UPS pathways are often
triggered by cellular stress, e.g., in hypoxic metastatic tumors and cells under low energy conditions. Some UPS
cargos are assisted by chaperones, but many others are released independently. Their release involves self-
sustained direct crossing of a membrane, either the cell membrane (Type I UPS) or organelles (Type III UPS).
The fundamental question here is how UPS secreted proteins enter organelles and how their essential
translocation across membranes is regulated. Defining the molecular regulatory mechanisms is of high
significance to drive new therapeutic strategies (e.g., UPS modulators) for diseases associated with their
perturbed cellular distributions. We propose a novel hypothesis that explains the regulated and directed release
of these key proteins in tumor progression. Hypoxia instigates a transient or enduring cellular acidification. In
this model, the interplay between the local acidity and membrane curvature determines the conformational states
and membrane-binding mode of these cargoes. In the context of a Type III UPS, this promotes self-sustained
protein translocation across endosomal membranes and ultimate secretion. To test this hypothesis, we will
determine the extracellular release mechanism of two important UPS cargo proteins, the brain-type creatine
kinase and sphingosine kinase isoforms 1 and 2. Extracellular release of these proteins in various cancers
contributes substantially to the survival of metastatic cells. This mechanism is mediated by extracellular
production of their biologically active products. The subjects of this proposal as potential amphitropic proteins
are able to reversibly interact with a membrane. Thus, defining the conformational rearrangements triggering the
release of these proteins entails identifying the conformational states that are populated under low energy status
of the hypoxic metastatic cells. Testing the involvement of reversible structural refolding and incorporation into
the membrane is challenging due to their dynamic states and the difficulties of gaining high-resolution structural
information of membrane-bound protein states, particularly the effects of membrane curvature on the protein
structure. Thus, we have combined approaches encompassing a range of complementary and cutting-edge
methods as well as cell biology studies. Using a similar methodology to study the release mechanism of other
key therapeutic targets will test commonalities and differences in their extracellular release mechanism.
Ultimately, our research has the potential to define an unconventional protein secretion pathway employed by
cancer cells and other pathological conditions. In addition, as a long-term goal, we will bridge our basic research
studies that elucidate mechanism with translational research by testing our key conclusions in model organisms.

Public health relevance
Project Narrative The proposed research is of high significance because it explores, at the molecular level, how brain-type creatine kinase and sphingosine kinase isoforms are regulated and released from cells to drive cancer progression and metastasis. It is relevant to public health because it will drive new therapeutic strategies for the diseases associated with their perturbed cellular distributions. Thus, the proposed research is relevant to the part of the NCI’s mission that pertains to advancing the knowledge foundation for greater understanding of the molecular basis of enzyme regulation in molecular pathways associated with cancer development and progression.